Novel methods for dynamic MRI of gastrointestinal motor function

Project Summary: Novel Methods for Dynamic MRI of Gastrointestinal Motor Function
Disorders of gastric motor function include gastroparesis, functional dyspepsia, gastroesophageal reflux
disease, among others and can affect >20% of the U.S. population. There is an urgent need to improve the
diagnosis and understanding of impaired gastrointestinal (GI) function. The dynamics of gastrointestinal
motion are quite complex, for example, stomach emptying is a tightly coordinated and synchronized process
with fundic accommodation, peristaltic and tonic antral contractions, pylorus opening and antral-pyloric
coordination. There are imaging tools that examine general movement of labeled meals from the stomach into
the intestines, but that miss the dynamic processes. Similarly, other tools like electrogastrography are able to
assess the frequency and temporal characteristics of stomach contractions but lack spatial resolution to assess
the coordination of different types of motor events occurring at specific locations along the gut. Magnetic
resonance imaging (MRI) has the potential to provide an unprecedented and detailed visualization of
gastrointestinal motor function, allowing new understanding and diagnosis of the pathophysiology of
gastrointestinal disorders. The overall goal of the project, therefore, is to develop MRI methods for high
spatiotemporal resolution imaging of the gut to improve the diagnosis and assessment of gastrointestinal
disorders. There have been breath-hold MRI studies of motion in the gut, but most have limited resolution or
volume of coverage, giving an incomplete picture of function. The slow frequency of motion of the stomach
and intermittent opening of the pylorus requires longer observation times that precludes the use of breath-hold
imaging. Thus, MRI methods must be fast enough and robust enough to resolve respiratory motion in addition
to motion of the stomach and intestines. High spatial resolution and SNR are required to visualize small
structures and allow for automatic segmentation and accurate quantitation of movement parameters. This
project relies on several novel approaches to the dynamic signal modeling, image acquisition, and image
reconstruction, to achieve new levels of spatiotemporal resolution for this application. The project has three
main aims: (1) Develop four-dimensional spatiotemporal models to capture dynamics due to respiration, gastric
accommodation, motility, emptying and coordination, (2) Design MRI acquisition and reconstruction methods
for high spatiotemporal resolution, free-breathing, dynamic imaging of the stomach and the intestines, and (3)
Evaluate acquisition and reconstruction methods in healthy volunteers. This project has the potential to
substantially advance the state-of-the-art dynamic imaging of gastrointestinal motor function. Importantly,
imaging in the free-breathing state will allow broader application to sicker populations and the methods will
allow for more quantitative and accurate assessment of motion.

Public health relevance
Project Narrative: Pathophysiology of gastrointestinal motor function underlies numerous disorders of gastrointestinal system, for example, gastroparesis. In this project, we will develop novel magnetic resonance imaging (MRI) methods for imaging the dynamic motor processes with at a high frame rate and in high resolution, all in the presence of respiratory and other motion. The success of this project will lead to an improved imaging methods to help visualize gastric motor function, enhancing the physiological understanding of a variety of gastrointestinal disorders.